Proteostasis, Neuroinflammation and Neurodegeneration in Frontotemporal Dementia

Proteostasis impairment, inflammation and gliosis are linked to neurodegeneration in frontotemporal dementia
(FTD) caused by GRN haploinsufficiency. FTD is the most common age-related dementia in people under 60
years of age. We showed that GRN-deficiency impairs the autophagy/lysosomal pathway (ALP) in neurons,
leading to neuronal accumulation and deposition of the toxic protein TDP-43, neurodegeneration, microglial
activation and inflammation. We performed proteomic studies on cortical FTD iPSC-derived neurons (iNs) and
microglia (iMG), and found dysregulated levels in several proteins linked to the ALP as well as to the ubiquitin
proteasome system (UPS). Some of the altered proteins have direct roles in assembly of the vATPase that is
required for lysosome acidification, as well as in lysosomal trafficking; we also found dysregulated levels of
several lysosomal hydrolases. We will leverage our proteomics data to look deeper into the underlying
mechanisms of proteostasis dysfunction in FTD. Normally glia (microglia and astrocytes) provide support for
neurons to repair damaged neurons and facilitate clearance of toxic proteins. Our new studies show that control
iMG co-cultured with cortical FTD iNs display process extension toward the neurons, consistent with the healthy
microglia attempting to repair patient neurons. However, when FTD i-MGs are co-cultured with control or FTD
iNs, they attack and kill the neurons. The toxic actions of FTD iMGs on iNs are dramatic, but it is not clear to
what extent the GRN deficiency impairs glial proteostasis, like it does in neurons, leading to hyperactivation and
if the inflammatory nature of glia contributes to drive neurodegeneration in FTD or if glia are primarily responding
to proteostasis impairment in GRN-deficient neurons. We hypothesize that dyshomeostasis is a unifying
mechanism underlying GRN-deficient FTD. GRN deficiency impairs proteostasis in neurons, reducing clearance
of toxic TDP-43 leading to neurodegeneration, and in glia causes activation of microglia and astrocytes and the
ensuing inflammation further drives neurodegeneration. We will test these hypotheses by better defining the
alterations in proteostasis in FTD glia by determining if autophagy flux, TDP-43 turnover and lysosomal functions
are altered in a cell autonomous manner in FTD iMG, or i-astrocytes (iAs) compared to FTD iNs. We will test if
FTD iMG, and iAs are hyperactivated and determine if this impairs their ALP. We will also test if
neurodegeneration in FTD is driven by proteostasis impairment in glia, iNs or both and in which cell type
abnormalities are evident first.

Public health relevance
The goal of our proposed study is to test the hypothesis that progranulin (PGRN) is a regulator of protein homeostasis and inflammation, and that loss of PGRN triggers pathobiological processes including dysfunction of autophagy-lysosome (ALP) and ubiquitin proteasome (UPS) protein clearance pathways, TDP-43 mislocalization, excessive inflammation in glia and neurodegeneration leading to frontotemporal dementia (FTD). We will investigate the underlying molecular mechanisms by which insufficient PGRN leads to ALP and UPS dysfunction in neurons, and whether the dysfunction presents in glia, how it is tied to glial inflammation, and if it promotes glial-driven neurodegeneration using cells differentiated from human FTD patient iPSCs.